NNTC Data Coordinating Center

Project Summary/Abstract
The Data Coordinating Center (DCC) supports the National NeuroAIDS Tissue Consortium (NNTC). The
consortium is composed of four NNTC Clinical Sites and the DCC that work cooperatively as a resource for the
research community, providing HIV/AIDS investigators with clinically annotated datasets of antemortem
information and associated postmortem tissue and fluids. The DCC works cooperatively with the NNTC Clinical
Sites to provide (1) management and database capabilities to ensure effective clinical and brain banking
operations; (2) scientific expertise in biostatistics and HIV epidemiology to support broad analyses of the NNTC
clinical database and analyses that support the recruitment and retention goals for the cohort; and (3) identify
gaps and provide solutions to neuroAIDS investigators. The DCC serves as the point of contact for users of the
resource (tissue and/or data requests) and services the requests from the time they are submitted through
fulfillment of the request and follow up with the requestor to provide the results of their research. The DCC
expanded to include the CHARTER study bringing in longitudinal participants and ancillary studies. In this next
funding period, the Global CERCH will be developed to enable collaborations and the sharing of specimens
and data relating to CSF escape, expanding the DCC's ability to support ongoing neuroAIDS research. The
DCC websites are used extensively for dissemination of resource information (query tools, reports, request
applications) and management tasks such as resource tracking, document libraries, and communication
activities. The DCC provides a central inventory of NNTC data and specimens. Along with this inventory,
additional research data such as bioinformatics datasets by the users of the resource are available. The DCC
promotes the NNTC through public relations materials including a comprehensive website and meeting
presentations. In the past funding period, the NNTC supported 356 separate research grants and 157 peer-
reviewed publications.

Public health relevance
Relevance Since 1998, the National NeuroAIDS Tissue Consortium (NNTC) has served as a valuable resource to the research community examining the cause and ways to prevent and treat neuroAIDS. This consortium has provided to this community well-characterized specimens with quality antemortem and postmortem data. The Data Coordinating Center (DCC) is an integral part of the NNTC, and provides services as well as a rich bioinformatics database serving as a consortium wide and national resource. Biostatistical, epidemiological, and bioinformatic capabilities are present to achieve the use of the NNTC internally and for external users.